Immune cells as a driver of cell non-autonomous aging

Project Summary
Aging and the chronic diseases associated with aging place a tremendous burden on our healthcare system and
reduce quality of life for the elderly. As our world population ages dramatically over the next three decades, the
burden will only increase. Hence, there is a great need to discover fundamental mechanisms of aging to develop
rationale strategies for minimizing the impact of aging on our health and economy.
There is general agreement that cell autonomous mechanisms contribute to aging. As cells accrue damage
over time, they respond by triggering individual cell fate decisions (e.g., senescence and apoptosis) that
ultimately disrupt tissue homeostasis and thereby increase risk of morbidity. However, more recently, there are
numerous lines of evidence indicating that cell non-autonomous mechanisms are critically important as well.
These cell non-autonomous mechanisms are likely much easier and safer to target therapeutically. Therefore
identifying and characterizing these mechanisms is a priority. To ask if “aging” just one tissue in mice is sufficient
to drive systemic aging, we generated a series of eight tissue-specific mutant animals in which DNA damage,
senescence and tissue dysfunction were increased in only one cell type or tissue at a time. Our preliminary data
indicate that “aged” immune cells play a key role in driving aging non-autonomously. Only in the hematopoietic
cell mutant mice were non-targeted, peripheral tissues dramatically affected in the first year of life, showing
increased senescence, inflammation and loss of homeostasis. The goal of this project is to fully define this novel
mechanism of immune cell-mediated, non-autonomous aging in vivo. The aims of the project are to: 1.
Determine the temporal order and extent of secondary senescence driven by an “aged” immune system.
The specific immune and non-immune cell types with increased senescence will be identified by qRT-PCR and
CyTOF at different mouse ages. The functional impact of the “aged” immune system on peripheral tissue
homeostasis will be determined by measuring disease-specific endpoints and age-related histopathology. 2.
Identify the immune cell type(s) that is most potent at driving systemic aging. This will be accomplished
by transplanting splenocytes and isolated immune cell populations into young senescence reporter mice,
followed by generation and characterization of cell-type specific mutant mice (e.g., T, B, NK cell or
subpopulations). 3. Identify the mechanism by which “aged” immune cells drive systemic aging. This will
be accomplished by serum transfer from the hematopoietic mutant mice into young senescence reporter mice
followed by transcriptomic analysis of isolated immune cell populations to identify secreted factors. These
putative pro-geronic factors will be validated by proteomics and functional validation.
Completion of these aims will identify and characterize a novel mechanism(s) of cell non-autonomous aging
driven by an aged immune system, which will lend itself to therapeutic targeting for extending human healthspan.

Public health relevance
Project Narrative Aging affects us all and brings increased risk of morbidity and mortality, depleting quality of life. Recent evidence indicates that damaged cells/tissues can “age” other non-damaged cells/tissues in the body. Our data suggests immune cells play a large role in this. Identification of which immune cells drive aging in trans and how they do it will promote new and safe approaches to slow age-related decline.